Summer Undergraduate Program to Advance Research and Equity in Pain and Neurological Health

Project Summary
Pain and neurologic disease are significant public health concerns. Sixty percent of Americans, more than 200
million people, are affected by at least one neurologic disorder. Chronic pain affects millions of people in the
U.S., resulting in high economic burden ($600 billion/yr) on society. The risk and burden of neurologic
disorders and chronic pain are disproportionally experienced by minoritized and medically underserved groups.
To advance the field in reducing the burden of pain and neurologic disease, we will need to better understand
treatment mechanisms and develop new therapies that are relevant and accessible for diverse populations;
while focusing on eliminating inequities in prevention, diagnosis, and access to evidence-based care. This
work will require creating opportunities to prepare the next generation of researchers who, early on in their
training, are exposed to principles of equity in pain and neurologic health. With this goal in mind, our proposed
training program, SPARQ: Summer Program to Advance Research and eQuity in Pain and Neurological
Health, aims to expose undergraduate students to pain and neuroscience research with a special focus on
pain inequities across the lifespan. SPARQ is designed as an innovative, interdisciplinary, and intensive short
term (9-week) mentored research skills building program supporting 10 undergraduate students per year. Our
first specific aim is to provide an immersive and rigorous mentored research experience in basic science,
mechanistic, and clinical research in pain and neuroscience, working in the labs of our diverse and
interdisciplinary faculty mentors. Interwoven with this experience is a didactic program that includes a core
curriculum of research seminars and workshops that provide training in research skills, writing, ethics,
understanding disparities in pain and neurologic health, and inclusive research practices. Students will have an
opportunity to present their research in poster and oral presentations at the end of summer Research
Symposium. Our second specific aim is to impart critical and tailored professional development capacity
building skills needed to successfully compete for higher educational opportunities and for successful research
careers. Students will receive support for their personal and professional growth; have opportunities to
participate in clinical observerships; and will receive individual mentoring from program faculty. Finally, our
third specific aim is to increase recruitment and training of underrepresented and disadvantaged students to
the field of pain and neuroscience research. We will use best practice strategies to recruit SPARQ applicants
from groups underrepresented in research through Seattle area community colleges and universities using
existing and developing new strategic community and academic partnerships committed to diversity, equity,
inclusion and belonging. Program evaluation is completed annually and reviewed with an advisory committee.
The long-term goal is to develop a cadre of diverse and interdisciplinary future researchers to meet the nation’s
biomedical workforce needs in research and clinical care of patients with pain and neurological disease.

Public health relevance
Project Narrative To advance the field in reducing the burden of pain and neurologic disease, we will need to better understand treatment mechanisms and develop new therapies that are relevant and accessible for diverse populations; while focusing on eliminating inequities in prevention, diagnosis and access to evidence-based care. The SPARQ program addresses a large unmet need in pain and neuroscience research to develop future researchers, to increase diversity in the research workforce in biomedical, behavioral and clinical sciences, and to reduce inequities in pain and neurologic health.